Innovation of Biobanking for Cellular Adoptive Immunotherapies Based on a First-in-Class Biocompatible Cryopreservation Technology for T and NK Cells and Their CAR-Engineered Products

SUMMARY
Previous support from NIH SBIR and Coulter Foundation awards allowed the CryoCrate team to develop a first-
in-class biocompatible cryopreservation medium product that doesn’t need any cell permeating and toxic
cryoprotectant. The product is trademarked as OdinSol®, and has been approved to provide significantly
improved efficiency in cryostorage of cell types that are essential for cell-based adoptive immunotherapies. The
OdinSol® technology also removes the requirement of serum and human products and secures long-term storage
in regular -80oC deep freezers.
Based on our former experience in FDA 510(k) submission, in this project, we organized the collaboration with
our regulatory consultant (Cardinal Health), contract manufacturing organizations (Bryllan), contract research
organization (WuXi AppTec), academic subcontract collaborator (the Center for Precision Medicine at University
of Missouri), to achieve the following milestones:
I. The production of OdinSol® meets GMP qualifications and biocompatibility assessment shows
compliance with FDA guidance for 510(k) submission as a storage device for transfusable cells;
II. The in vitro and in vivo evaluation of safety and efficacy demonstrates the OdinSol® technology to be
superior to existing cryopreservation protocols with respect to preserving viability and functionalities
of T, NK and CAR-T cells;
III. Based on those qualifications, we will complete of the 510(k) submission and finalize of the production
line based on further FDA feedback before the end of the project period.
We expect future clinical use of the OdinSol® technology within three years after the FDA clearance, providing
the industry of cell therapies with a highly efficient biocompatible cryostorage platform.

Public health relevance
NARRATIVE The long-term vision of CryoCrate LLC related to this project is to commercialize a “First-in-Class” biocompatible cryopreservation medium product for biomedical applications associated with cell-based therapies for cancers. The product, OdinSol®, eliminates the need for any toxic cell permeating cryoprotectant (e.g., DMSO), any liquid nitrogen facilities, any animal or human products (e.g., animal serum or human serum albumin), which are unfortunately required by traditional cryopreservation medium products and protocols. In this project, we will obtain qualifications associated with Good Manufacturing Practice production, biocompatibility, safety and efficacy testing, and secure 510(k) clearance, to pave the path to commercialization.